Guideline Adoption in HRSA-Funded Health Centers

As part of the Cancer Moonshot, the U.S. Department of Health and Human Services (HHS) Health Resource and Services Administration (HRSA) Office of Women’s Health, in partnership with other HHS agencies, is sponsoring a Roundtable meeting series (“the Roundtable”) and the development of technical assistance materials to support the goal of accelerated cervical cancer prevention and control within HRSA-supported and safety-net settings of care. This initiative supports the uptake of clinical screening and management guidelines, prevention (e.g. HPV vaccine), distribution and uptake of scientific innovations (e.g. self-collection) and strengthening of Federal coordination for cervical health services in HRSA-supported and safety-net settings of care. The Federal Interagency Partners Team (HRSA ORO, NIH NCI (DCEG and HDRP), NIH ORWH, CDC DCPC, and HHS OPA) is working together to strengthen approaches to cervical cancer prevention, screening, and treatment within select HRSA-supported and safety-net programs. This collaboration bridges the Federal priorities of cancer research by NCI and health care delivery by HRSA-supported and safety-net settings of care. Safety-net settings of care, for the purposes of this effort, include: Health Centers (HCs) funded by Section 330 of the Public Health Service Act, Ryan White Clinics, Critical Access Hospitals, Rural Health Clinics, and Title X service sites. In terms of reach, the HRSA Community Health Center Program is comprised of nearly 1,400 HCs operating over 13,000 service delivery sites, in US states and territories, to increase vulnerable population’s access to comprehensive, culturally competent, quality primary care services.